Modeling of macromolecular interactions in the cell

Project Summary
Recent developments in the protein structure prediction field showed that protein models can routinely reach
unprecedented levels of near-experimental accuracy. In this context, modeling macromolecular interactions in
the living cell is becoming more central than ever before. Classical techniques for modeling macromolecular
interactions include docking and biomolecular simulations. While the latter can give access to the dynamics and
the kinetics of the interactions, they are either relatively slow, if carried out at all-atom representation, or coarse-
grained. Docking methods are more efficient, but do not account for the kinetics of the association. Our recent
study bridged the two modeling methodologies to put forward an approach capable of reaching unprecedented
simulation timescales at all-atom resolution. This proposal aims at advancing this approach in multiple directions
that reflect the diversity and the scope of macromolecular interactions in the cell. To accomplish that, we will
apply efficient simulation protocols to different types of macromolecules in all-atom representation to sample the
intermolecular energy landscapes pre-computed by docking. The project will involve characterization of the
intermolecular energy landscapes for different types of macromolecules; simulation of the macromolecular
interactions by sampling the energy landscapes; development of public resources incorporating techniques
developed in the project; and application of the simulation approaches to molecular systems of biological interest.
The long-term goals are to gain insights into fundamental principles of molecular processes in living systems,
including dynamics and kinetics of the macromolecular interactions and to develop adequate structural
characterization of cells at extra-long timescales. The analysis of the intermolecular landscapes for different
macromolecular types will benefit our understanding of their interaction and provide framework for the docking.
Docking protocols will be advanced for adequate representation of the full intermolecular energy landscape,
including the multiplicity of transient interactions. New simulators of crowded macromolecular environment will
be developed to sample the energy landscape. The project will develop powerful approaches to modeling
macromolecular interactions in the cell, publicly available to the scientific community, facilitating better
understanding of the cellular mechanisms.

Public health relevance
Project Narrative The proposed research will facilitate development of modeling techniques capable of delivering starting points for structure-based drug design by providing structural information on docking modes and association patterns of existing and potential drug targets.